Core A: Administrative Core

ADMINISTRATIVE CORE SUMMARY/ ABSTRACT
The Administrative Core plays a vital role in the UCSD ADRC by providing scientific leadership, fiscal
management, operations oversight, and administrative support to the Center's Cores and training program. Its
primary objective is to ensure effective coordination and collaboration among the various components of the
Center. The specific aims of the Administrative Core include 1) maintaining an effective leadership team, 2)
fostering strong and cohesive Cores, 3) supporting partnerships and cross-center initiatives, 4) coordinating
programs for Developmental Projects and REC scholars, 5) interacting with advisory committees and program
officers, 6) overseeing data transmission and sample distribution, 7) providing fiscal and staff management,
and 8) communicating ADRC activities and research findings to relevant stakeholders. By fulfilling these aims,
the Administrative Core promotes the Center's mission and theme while supporting integration across
departments, scientists, and community partners. It guides the overall priorities and facilitates interactions to
advance Center goals and ensure resources are allocated appropriately. Fiscal management is a key aspect,
providing for efficient use of resources and amplifying productivity and innovation in priority scientific areas.
Additionally, the Administrative Core plays a role in selecting and awarding development research and training
grants, promoting collaboration among clinicians and researchers across UCSD and other outstanding local
and national research institutions. The Administrative Core also works closely with the ORE core in ensuring
efficient dissemination of the latest research findings and opportunities for engagement with the UCSD ADRC,
informing the broader community about the Center's work and encouraging involvement.
Overall, the Administrative Core serves as a critical component of the UCSD ADRC, facilitating the effective
functioning of the Center and promoting its mission of advancing Alzheimer's disease and related dementias
research.